Administrative Core

The CMCR's Administrative Unit (AU) provides centralized services that support the Center Director, project leaders, core directors and members in carrying out the Center's overall research mission. Services include: * Grants management and fiscal reporting * Managing meetings, events, and seminars *IACUC approval *Comprehensive reporting on the research activities of the Center's members and shared resource facilities * Data support services *Provide a central Interface between the Center and the various participating institutions and with Einstein administration *Oversee compliance with Institutional policies and sponsor requirements * Oversee development and implementation ofthe Center's plans: business plans, intellectual properties and collaboration and sponsorship with industry and reporting to NIAID. The responsibilities of tiie CMCR's administrative unit are to: * Provide centralized administrative services to the Director, Project Leaders, Core Directors and Shared Resources * Provide Grants management and oversight of CMCR budget, fiscal reporting and subcontracting * Coordinate, facilitate and provide administrative input in all CMCR planning and evaluation activities * Submit IACUC application and maintain approvals * Communication and organization of CMCR meetings, events, and seminars * Oversee operations of CMCR shared resources - Core facilities *Manage CMCR research administration informatics to support reporting and recordkeeping